Investigating the role of cGMP signaling in glaucomatous neurodegeneration

PROJECT SUMMARY
Glaucoma is the world’s leading cause of irreversible blindness, which evolves from degeneration of retinal
ganglion cells (RGCs) and their axons which form the optic nerve. Glaucoma is characterized by sensitivity to
intraocular pressure (IOP), with susceptibility increasing with age. Current treatments lower IOP to relieve
stress to RGC axons, but many patients continue to lose vision. Thus, an unmet clinical need is a treatment
that addresses RGC degeneration directly. Our long-term goal is to probe the mechanisms of RGC
degeneration in glaucoma to identify novel therapeutic targets to protect and potentially restore vision.
The objective of this proposal is to investigate the potential role of the cyclic nucleotide guanosine
monophosphate (cGMP) in countering RGC degeneration in glaucoma. Glaucoma involves complex
pathogenic processes in the retina and optic nerve. These include interactions between RGCs, astrocyte glia,
and microvascular elements, which is our focus here. cGMP is a vasoactive second messenger produced by
the nitric oxide (NO)-sensitive enzyme soluble guanylate cyclase (sGC, referred to in this proposal as GC1),
which relaxes vascular smooth muscle tissue to increase blood flow. Longstanding evidence suggests that
cGMP signaling is impaired in glaucoma. Patients show decreased ocular cGMP, while polymorphisms in
genes encoding GC1 lead to increased incidence of glaucoma with early paracentral visual field loss. Our
published work demonstrates that aberrant cGMP signaling induced by global knockout of GC1 (GC1-/-) leads
to gross morphological abnormalities in retinal astrocyte and vascular networks that precede age-related RGC
degeneration. Finally, increasing cGMP with a PDE-5 inhibitor (tadalafil) protects RGCs in multiple murine
models of glaucoma. Based on these findings, this proposal will test the central hypothesis that disrupted
cGMP signaling in glaucoma degrades astrocyte-vascular networks, leading to RGC metabolic stress
and subsequent axon degeneration. As a corollary, we will test whether increasing cGMP signaling
specifically in either astrocytes or RGCs slows progression. This hypothesis is supported by preliminary data
that show aging GC1-/- mice exhibit (1) reduced retinal glucose uptake coincident with decreased glucose
transporter-1 (GLUT1) and mitochondrial proteins and (2) increased RGC oxidative stress and RGC
degeneration. Here we will discern age vs. IOP-dependent effects of cGMP signaling by combining cell-specific
transgenics and viral-targeted gene disruption with imaging, electrophysiology, and visual function testing in
our microbead occlusion model in mice. In Aims 1 and 2 we investigate how cGMP signaling alters astrocyte
and vascular cellular connectivity, and RGC mitochondrial function and oxidative stress. In doing so, these
experiments will reveal novel cell-specific roles of cGMP in the retina that may be targeted therapeutically
to preserve vision in glaucoma by abating RGC degeneration, possibly by boosting mitochondrial function and
reducing metabolic stress – in Aim 3 we test this possibility.

Public health relevance
Public Health Relevance Glaucoma is the leading age-related cause of irreversible blindness worldwide and will afflict an estimated 112 million people by 2040. The disease causes retinal and optic nerve degeneration through sensitivity to ocular pressure, but lowering pressure does not always stop progression. The work proposed here investigates a novel IOP-independent role for cGMP in the pathophysiology of glaucoma and may identify a novel opportunity for therapies to slow degeneration and preserve vision.